Histology/Imaging Core

The overall objective of the Histology/Imaging Core of the Cleveland DDRCC is to provide high-quality morphologic analyses of the gastrointestinal and liver systems in experimental animal models and human Gl and liver-related pathologies. In addition, the major goals of the Histology/Imaging Core is to support new and established investigators at Case Western Reserve University and the Cleveland Clinic Foundation who do not have a direct focus on digestive disease-related research to enter this exciting field of investigation and to encourage collaborations among DDRCC members working in the areas of digestive Inflammation and Metabolism. The Histology/Imaging Core is committed to providing basic and fundamental histological and immunohistochemical methodologies essential to Gl and liver-related research, while at the same time implementing state-of-the-art technologies, such as small animal imaging. The specific aims proposed for the DDRCC Histology/Imaging Core are: 1) Provide basic, high-quality histologic and immunohistochemicai services in a cost-effect and timely fashion; 2) Provide initial service, consultation and subsequent training for special immunohistochemical staining in Gl and liver tissues; 3) Provide consistent and validated histological scoring of gastrointestinal and liver inflammation for preclinical and clinical studies; 4) Provide publication-ready photo documentation of acquired histological, immunohistochmical, and/or immunoflourescence-stained images; 5) Provide access to an animal tissue repository of histological blocks and slides of various models of Gl and liver inflammatory and metabolic disease; 6) Provide access to cutting-edge technologies for in vivo small animal imaging through a Small Animal Imaging SubCore to precisely address the extent, severity, and occurrence of lesions in animal models of gastrointestinal and liver inflammation and metabolism; and, 7) Provide consultation and training in all aspects of Gl-related morphology and imaging techniques. Through these aims, the Core will facilitate the production of high quality research in digestive diseases in a cost-effective and time-efficient manner, and enhance the rate, depth, and breadth of research in digestive Inflammation and Metabolism throughout CWRU and CCF.

Public health relevance
RELEVANCE (See instructions): This Core aims to provide high-quality, cost-effective and time-efficient histological and imaging analysis of human and animal tissues of digestive inflammatory and metabolic diseases, such as IBD, hepatitis, metabolic syndromes, and obesity. These conditions affect millions of individuals in the US, and facilitating their study will increase the chance of uncovering key pathogenic mechansims and developing new therapeutic anoroaches